Adding Inspiratory Muscle Training to Optimize Cardiac Rehabilitation for Heart Failure

Project Summary/Abstract: Exercise intolerance and exertional dyspnea are hallmarks of heart failure with
reduced ejection fraction (HFrEF). HFrEF patients have impaired locomotor muscle blood flow that directly
contributes to submaximal exercise intolerance (and thereby limiting activities of daily living). Patients with HFrEF
also exhibit exaggerated inspiratory muscle oxygen cost of breathing – a candidate mechanism contributing to
exertional dyspnea in HFrEF. American College of Cardiology/American Heart Association guidelines
recommend cardiac rehabilitation (CR) for patients with HFrEF (Class I recommendation). A core component of
CR is exercise training. However, exercise training has a minimal impact on locomotor muscle blood flow and
exertional dyspnea during submaximal exercise in HFrEF. Inspiratory muscle dysfunction is highly prevalent in
HFrEF. In this context, inspiratory muscle training (IMT) is a clinically relevant intervention that targets the
inspiratory muscles. IMT improves inspiratory muscle function, exercise tolerance, and quality of life in HFrEF.
Importantly, IMT combined with exercise training leads to greater improvements in exercise tolerance and
exertional symptoms than exercise training alone in patients with HFrEF. Our scientific premise is that the
addition of IMT to CR increases locomotor muscle oxygen delivery and reduces inspiratory muscle oxygen cost
of breathing during exercise contributing to the improvements in exercise tolerance and exertional symptoms
with IMT combined with CR in HFrEF patients. The Specific Aims that will be explored in this proposal include:
1) To test if IMT combined with CR improves locomotor muscle blood flow during exercise compared to CR alone
in patients with HFrEF, and 2) To test if IMT combined with CR reduces the exaggerated inspiratory muscle
oxygen cost of breathing and improves ventilatory function to a greater extent than CR alone in patients with
HFrEF. Both Aims are framed with testable hypotheses and clearly associated with the experimental protocol
and statistical analysis plan. Our integrative, highly collaborative research team has the intellectual and technical
expertise, established infrastructure, and clearly demonstrate high feasibility in performing all facets of these
studies to address and interpret the Aims we have proposed. Our proposal addresses an important problem
by focusing on ideas that are a significant departure from current paradigms on physiologic adaptations to
exercise training in HFrEF patients. Our preliminary data and review of the rigor of prior research supporting
our Aims provide strong justification for our innovative experimental design and gold standard techniques to
reveal the physiologic mechanisms contributing to the improved exercise tolerance and exertional symptomology
with IMT combined with CR in HFrEF. Finally, we have aligned our scientific premise, aims, and associated
hypotheses with the NHLBI Research Priorities and the current NIH review criteria that emphasizes significance,
impact, and innovation for R01 applications.

Public health relevance
Project Narrative Supervised exercise training in the cardiac rehabilitation (CR) setting is guideline recommended for heart failure with reduced ejection fraction (HFrEF); however, exercise training does not elicit improvements in locomotor muscle oxygen delivery or exertional dyspnea during submaximal exercise for these patients. Compelling evidence indicates that inspiratory muscle abnormalities contribute to exertional symptomology in HFrEF, and in this context, inspiratory muscle training combined with exercise training has led to greater improvements in exercise tolerance and exertional dyspnea than exercise training alone in HFrEF patients. In this application, we investigate the cardiovascular and inspiratory muscle physiologic adaptations arising from inspiratory muscle training combined with CR contributing to the improved exertional symptomology in patients with HFrEF.